Diabetes Research and Training Center

PROJECT SUMMARY – CENTER OVERVIEW
The Chicago Diabetes Research and Training Center (DRTC) is a Chicago area Diabetes Research Center that
is centered at the University of Chicago with the participation of investigators from the Northwestern University,
the University of Illinois at Chicago, the Illinois Institute of Technology, and the Medical College of Wisconsin.
Each institution has distinct scientific strengths yet shares a common interest in diabetes and related research.
The DRTC includes 147 members, a growth of 20% in the last 5 years, with a total annual direct research funding
of $124 million, of which $34 million comes from the NIDDK. The mission of the DRTC is to promote new
discoveries and enhance scientific progress by supporting cutting-edge basic and clinical research on the
etiology of diabetes and its complications with the goal of rapidly translating research findings into novel
strategies for the diagnosis prevention, treatment and cure of diabetes and related conditions. To this end, we
propose the following Aims:
Aim 1. Create an intellectual and physical environment that supports important and innovative diabetes
research.
Aim 2. Raise awareness and interest in fundamental and clinical diabetes research in the greater Chicago
area as well as nationally.
Aim 3. Enhance diabetes research, education and training opportunities for patients, students, fellows,
scientists and clinicians.
Aim 4. Attract and retain early-stage investigators and investigators new to diabetes research;
Aim 5. Provide high quality core services that leverage funding and unique expertise and serve the
diabetes community locally, regionally and nationally.
Aim 6. Connect researchers and foster interdisciplinary collaborations especially in emerging areas of
research, to catalyze new ideas and scientific approaches.
Aim 7. Promote the translation of scientific discoveries from the bench to bedside to community to
improve public health.
Aim 8. Participate actively in and contribute to the National Diabetes Research Center program.
The DRTC will achieve these goals through the support of Biomedical Research Cores in Cell Biology,
Physiology, and Genetics and Genomics (a Regional/National Resource), which provide cutting-edge and state-
of-the-art services; through a Pilot & Feasibility Program to attract early stage investigators and investigators
new to diabetes research; and through an Enrichment Program that promotes engagement, communication, and
the exchange of ideas among patients, students, scientists and clinicians.

Public health relevance
PROJECT NARRATIVE – CENTER OVERVIEW The mission of the Diabetes Research and Training Center is to promote new discoveries and enhance scientific progress by supporting cutting-edge basic and clinical research on the etiology of diabetes and its complications with the goal of rapidly translating research findings into novel strategies for the diagnosis prevention, treatment and cure of diabetes and related conditions. The Center provides strategic vision, cutting-edge, high quality and cost-effective services and resources, and gives opportunity to current and next generation scientists to fluorish in a highly collaborative and productive environment.